Deciphering Post-transcriptional Gene Regulatory Networks During Periods of Host-Pathogen Interaction and Innate Immune Activation

Project Summary
We are requesting supplemental funds to the parental grant R35GM119569 to purchase a Beckman-Coulter
ultracentrifuge (Optima XE-100 IVD) and two rotors (45Ti and SW32Ti). The Ascano laboratory routinely
utilizes density gradient ultracentrifugation as a means of concentrating viruses and isolating them from cellular
debris during propagation. However, the current ultracentrifuge (Beckman Optima LE-80K) is over 19 years old
(was purchased in 2003) and has had to be serviced twice in the last two years, during which it experienced
significant downtimes because replacement parts for an obsolete piece of equipment are harder to source – as
communicated by Beckman repair technicians servicing the instrument. Given its age, the costs to repair the
current instrument only continue to increase. Moreover, the two rotors that the lab currently use, a 45Ti and a
SW32Ti, are also older - with the newest one (SW32Ti) being purchased in 2014; both rotors are no longer
under warranty. We are principally requesting funds to secure a new instrument, in anticipation of the inevitable
decommissioning of the current departmental ultracentrifuge. An ultracentrifuge is a mission-critical piece of
equipment enabling the laboratory to isolate and concentrate various RNA viruses to high titer and purity. This
is a necessary and essential step for preparing one of our most important biological reagents, which we require
for three of four research directions of the R35 parental grant.

Public health relevance
Narrative The Ascano laboratory requests supplemental funds to their grant R35GM119569 to purchase a Beckman- Coulter ultracentrifuge and two rotors, as a replacement of the current instrument machine that the lab uses which is over 19 years old and has had to be serviced with increasing frequency. An ultracentrifuge is a mission-critical piece of equipment enabling the laboratory to isolate and concentrate various RNA viruses to high titer and purity – which is a required biological reagent for three of four of research aims of our parental grant. The purchase of a new ultracentrifuge and its associated rotors secures the lab’s experimental workflow, thus helping us fulfill our research goals and aims by minimizing our risk from being significantly delayed by protracted repairs owing to its obsolescence.